Blood-Brain Barrier Dysfunction in Alzheimer’s Disease: New Mechanistic Insights and Therapeutic Strategies

Amyloid β (Aβ) is a key driver of blood-brain barrier dysfunction in Alzheimer’s disease (AD). A leaky and
dysfunctional barrier, in turn, contributes to AD pathology and cognitive decline. In addition to Aβ, another key
driver of AD pathology is microtubule-associated protein tau (tau). In AD, intracellular tau accumulates in
neurons, contributing to neurodegeneration and cognitive decline. Tau also exists as extracellular tau, which
activates various signaling pathways. Importantly, elevated extracellular tau contributes to neurodegeneration
and cognitive decline. We found that extracellular tau induces barrier dysfunction and is transported across the
brain capillary endothelium into the vascular lumen. These findings support the conclusion that both Aβ and tau
contribute to barrier dysfunction and cognitive decline in AD. However, the mechanism underlying tau-induced
barrier dysfunction is unknown and tau transport has not been described. Thus, therapeutic strategies that repair
Aβ/tau-induced barrier dysfunction are not available. In this application, we address this critical unmet need and
propose to determine the mechanistic link between tau signaling and barrier dysfunction, define tau transport at
the blood-brain barrier, and develop a strategy to repair Aβ/tau-induced barrier dysfunction. Our objective in this
proposal is to establish a mechanism-based intervention targeting Aβ/tau to treat barrier dysfunction in AD.
Based on preliminary data, our central hypothesis is that targeting SIRT1/NOX repairs Aβ/tau-mediated barrier
dysfunction and slows cognitive decline in APP/tau models. Our rationale is that this proposed research has the
potential to provide a basis for a disease-modifying intervention to treat barrier dysfunction in AD patients. The
hypothesis will be tested by pursuing three specific aims: 1) Identify the mechanism responsible for tau-induced
barrier dysfunction. 2) Determine tau transport across the blood-brain barrier. 3) Develop a therapeutic
intervention to repair Ab/tau-induced barrier dysfunction. In Aim 1, we will identify signaling steps through which
tau induces barrier dysfunction in isolated brain capillaries from wildtype and KO mice and in isolated human
brain capillaries. In Aim 2, we will define tau transport across the capillary endothelium in vivo and in human
brain capillaries. In Aim 3, we will block Ab and tau signaling to repair barrier dysfunction and evaluate the benefit
of this strategy to slow cognitive decline in two preclinical APP/tau models. The proposed research is innovative
because it represents a new and substantive departure from the status quo to a disease-modifying combination
therapy focused on both Aβ and tau aimed at new molecular targets to repair barrier dysfunction and slow
cognitive decline. The proposed research is significant because it is expected to create a paradigm shift in our
understanding of barrier dysfunction in AD and constitute a crucial step toward developing a mechanism-based
intervention to repair barrier dysfunction in patients.

Public health relevance
The proposed research is relevant to public health because it is expected to advance our understanding of the mechanisms underlying blood-brain barrier dysfunction and potentially establish a new disease-modifying treatment strategy that repairs barrier dysfunction to slow cognitive decline in Alzheimer’s disease. Thus, the proposed research is relevant to the missions of the NIH/NINDS and the NIH/NIA that pertain to developing fundamental knowledge that will help reduce the burden of neurological disease and improve health and well- being in our aging population.